USHER SYNDROME--CLINICAL AND MOLECULAR STUDIES

The purpose of this project are to document the clinical features of Usher syndrome, to refine the localization, and eventually to isolate the genes causing this disease.